The impact of diet patterns and PUFA-related polymorphisms on ulcerative colitis in Hispanics

Summary

Ulcerative colitis (UC) is a devastating immune-­mediated disease that is on the rise globally. In our prior study,
we found that Hispanics have less severe disease than non-­Hispanics, but yet within one US-­born generation
develop a disease course that is similar. Differences in adoption of a Western diet between US-­ born and
foreign-­born Hispanics could explain differences in UC severity observed. A Western diet, high in n-­6 to n-­3
polyunsaturated fatty acids (PUFA), is up to 10-­20 times the recommended intake and is considered pro-­
inflammatory. However, heterogeneity of results in dietary intervention studies suggests that underlying genetic
variation in PUFA metabolism may modify diet effects. Our preliminary data indicates that Hispanics with UC
have polymorphisms in PUFA not present in Hispanic controls. In UC, disease activity measured by rectal
bleeding, number of bowel movements, and urgency correlates with endoscopic inflammation. I hypothesize
that Hispanics with UC whose diet follows a higher Western dietary pattern, defined by a reproducible dietary
pattern score, have more active disease, than those whose diet scores are lower. Further, I propose that
carriage of PUFA variants augments the effect of a Western diet on relapse leading to a disproportionate pro-­
inflammatory effect of the diet. In this study, I examine the influence of a Western dietary pattern on remission
and relapse of UC among Hispanics (Aim 1). We will test whether PUFA variants influence relapse and
enhance the effect of a Western diet on UC relapse (Aim 2). A total of 320 self-­ identified, Hispanic participants
with UC are followed at our GI clinics and we will include these for our diet portion in Aim 1. We will include a
total of 691 Hispanics with UC and 900 Hispanic controls for our Aim 2 genetics portion. We have detailed
demographic and clinical information on these patients, as well as whole genome sequencing of PUFA
variants. Participants will be asked to complete a validated food-­frequency dietary questionnaire, at baseline
and at 1-­year follow up. Disease activity using the validated simple clinical colitis activity index will be assessed
at baseline and at 1 year follow up in combination with fecal calprotectin. We will calculate scores for a
Western dietary pattern and determine the influence of diet on relapse using multivariable regression analysis.
In Aim 2, we will examine the effect of PUFA variants on relapse and also determine gene-­environment
interactions influencing disease activity between PUFA variants and Western diet. Results gathered from this
study will be a step towards personalizing IBD treatment by targeting specific dietary patterns in Hispanics with
highest metabolic genetic risk.

Public health relevance
Project Narrative This prospective study will examine dietary and genetic underpinnings of Hispanics with ulcerative colitis (UC) and determine risk for remission and relapse over the course of 1 year. At the end of this study, we seek to gain a better understanding of the role of a Western diet on UC relapse when underlying genetic susceptibility for abnormal polyunsaturated fatty acid (PUFA) metabolism exists. The findings from this study may guide food-based recommendations based on individual genetic variation in future studies.